Administrative Core

PROJECT SUMMARY
The Administrative Core (AC) will coordinate the activities of the Service Cores (Aim 1), and
will engage the local vision research community with respect to providing information regarding
core activities and available resources (Aim 2). In the coordination role, the Steering
Committee will be an essential component in ensuring that resources are fairly allocated, and
that the offered services are delivered with outstanding quality. The AC will also communicate
with vision researchers at The University of Iowa to keep them informed concerning Service
Core utilization, gather feedback on Core activities, and ensure that the selection of offered
services remain relevant and state-of-the-art over time. In addition, the Administrative Core will
facilitate training within The University of Iowa Vision Research community (Aim 3). This will be
achieved by the organization and implementation of an annual training meeting related to
vision research and key methodologies needed for state-of-the-art vision research. The
symposia will be targeted at students, post-doctoral trainees and new junior faculty.
Importantly, in these pandemic times the AC will aid in keeping vision research laboratories
and the Service Cores productive during the pandemic (Aim 4). To achieve this, the
Administrative Core will oversee, provide, and coordinate COVID-19 molecular testing to all
vision research laboratory personnel at The University of Iowa including the staff of the Service
Cores enabling laboratories to remain open, safe, functional and efficient. The ongoing delivery
of the Administrative Core aims will allow vision scientists to enhance their individual and
collective research programs substantially, and thereby drive discoveries, innovation, and
treatments.